REACH Center Administrative Core

PROJECT SUMMARY - ADMINISTRATIVE CORE
The Administrative Core aims to promote research using big data to explore health-protective and equitable
climate solutions through funding and coordination of the Developmental Core, Community Engagement Core,
and Exposure Assessment Core. The Administrative Core coordinates the REACH Center’s multi-institutional
partnerships that achieve the Center’s goal of leveraging the strengths of multiple institutions in the National
Capital Region to bridge novel geospatial datasets to climate solutions that advance health and equity. The
Core facilitates innovative approaches for this partnership that draw from the complementary areas of
expertise of the participating institutions. The Director and Co-Directors, advisers, and support staff of the
Administrative Core will (1) provide leadership and governance of the Center; (2) provide administrative and
fiscal oversight and management; (3) propel innovative approaches to spark multi-institutional partnerships
across collaborating Center institutions; (4) drive collaboration and communication between investigators and
government and community partners, NIH, and the Climate Change and Human Health Research Center
Coordinating Center and Community of Practice. The Center’s management structure is organized into an
Executive Committee consisting of the Directors and Co-Directors of each Core plus one institutional
representative from each of the collaborating institutions (George Washington University, George Mason
University, Howard University, and Environmental Defense Fund). The Executive Committee will receive
guidance from an Internal Advisory Board and an External Advisory Board. The Administrative Core will
facilitate and coordinate activities across a Community Engagement Core, a Developmental Core, and an
Exposure Assessment Core. Administrative Core Co-Directors will serve as liaisons to each of these Cores,
providing a bridge between the Cores and the Administrative Core that enhances the functioning of the Center.
Our leadership team is diverse and unique, with expertise in health sciences, climate and atmospheric
sciences, clinical medicine, biostatistics, and community health science. With the Administrative Core
leadership, the REACH Center cultivates a diverse, multi-disciplinary, collaborative research team that has the
capacity to successfully compete for action-oriented NIH research on climate and health.